2/2 Partnership for the Advancement of Cancer Research: NMSU & Fred Hutch

ABSTRACT
The Partnership between New Mexico State University (NMSU), an Institution Serving Underserved Health
Disparities Populations and Underrepresented Students (ISUPS), and Fred Hutchinson Cancer Center (Fred
Hutch), a Comprehensive Cancer Center, has matured into a strong, mutually beneficial partnership from its
start as a U56 (2002-2007) and three cycles as a U54 (2007-2023) Partnership. Over the past twenty years,
NMSU has increased its commitment to cancer research, and Fred Hutch has expanded its efforts in cancer
prevention, education, and health disparities. The Partnership has expanded and adapted opportunities for
research, education, training, and community engagement for historically excluded communities (HECs) in the
U.S. Southwest and Pacific Northwest, responding to its mission of improving cancer health equity. Population
health sciences and transdisciplinary studies are the focus of joint Research Projects to a greater extent than
in previous cycles. Expansion of the research education portfolio parallels an increased breadth of cancer and
health disparities Research Projects. Lastly, the Partnership has amplified the voices of the communities it
serves through community engaged research practices. The Partnership’s goals for the next U54 cycle are to
further increase excellence in cancer research, cancer education, and outreach and dissemination portfolios
while working towards accomplishing larger transformational changes within the Partnership. This competing
renewal application formulates and implements three Guiding Principles for the Partnership: Restructuring
Scientific Environments, Restructuring Scientific Processes, and Restructuring Scientific Engagement. These
principles bring new opportunities to strengthen equity, inclusion, and diversity across all activities proposed by
this U54 Partnership in support of the following three Specific Aims (1) Continue to develop a diverse portfolio
of robust cancer Research Projects that span clinical, basic and population health sciences (2) Implement,
evaluate, and improve our research education programs for current and future scientists from historically
excluded communities (HECs) (3) Collaborate with community organizations on outreach programs in New
Mexico and Washington State that work with underrepresented populations to reduce health disparities.
To achieve these aims, the Partnership has assembled innovative cancer Research Projects that address an
unmet regional needs and benefit from strong community input. Each Core - Administrative, Planning and
Evaluation, Research Education About Cancer and Health (REACH), Outreach and Resource for AcademIc
SuccEss (RAISE) - has also proposed activities to implement the Guiding Principles. The Partnership
formulated activities that are highly integrated across Research Projects and Cores to provide the necessary
resources to participants while advancing progress to meeting the Partnership’s mission.

Public health relevance
PROJECT NARRATIVE The collaboration between New Mexico State University (NMSU) and Fred Hutchinson Cancer Center (Fred Hutch) with its 20-year history of innovative and impactful partnership seeks to further support cancer research at NMSU, increase participation in health disparities research at Fred Hutch, and recruit, train and support underrepresented students and Early Stage Investigators in cancer research careers. The Partnership seeks to deliver outreach and education on cancer to underserved populations in the US southwest and Pacific northwest.